Cav1.2 in bladder physiology and pathology

Abstract: The L-type voltage-gated calcium channel Cav1.2 is responsible for the excitation-contraction
coupling of bladder smooth muscle (BSM), making it an attractive drug target for the treatment of lower urinary
tract symptoms (LUTS). Nifedipine, a Cav1.2 antagonist, inhibits BSM contraction. However, trials of nifedipine
and other calcium channel blockers (CCBs) for LUTS patients were unsuccessful. On the contrary,
cardiologists and epidemiologists have consistently reported that intake of CCBs like nifedipine causes higher
voiding frequency and worsen the severity of LUTS in patients. The mechanism of this mystery has never been
answered, which hampers its application as a useful drug target for LUTS treatment. We have discovered that
ketamine functions as a Cav1.2 antagonist to cause ketamine cystitis - a painful bladder syndrome presenting
as frequency, small voids, and incontinence. We have discovered that intravesical infusion of nifedipine or
ketamine directly induces voiding frequency in mice. Conversely, Cav1.2 agonist induces fewer but larger
voids, suggesting Cav1.2 agonists as potential novel therapeutics for LUTS. In addition to BSM, we have
further discovered the presence of Cav1.2 in urothelium, and urothelial specific deletion of Cav1.2 (UCav1.2-/-)
in mice results in dramatic voiding frequency, small bladder capacity, and diminished voiding efficiency, a
phenotype closely resembles that produced by intravesical infusion of nifedipine in mice, and the symptoms of
patients with ketamine cystitis or CCB users, indicating a crucial role of Cav1.2 in urothelial function and
bladder pathology. We propose that disruption of Cav1.2 signaling causes deficient urothelial exocytosis and
reduced bladder capacity, which leads to abnormal mechanosensation by elevated ATP signaling and result in
voiding frequency. We will test our hypothesis by the following two aims: Aim 1. We will define bladder storage
abnormality in UCav1.2-/- mice by studying Cav1.2 regulated umbrella cell (UC) exocytosis. We will use
videocystometry and electrophysiology to determine UC exocytosis and bladder urodynamics, and test its
Cav1.2- and AC-cAMP-PKA- dependence. We will further manipulate Cav1.2 expression by gene silence or
knockin specifically in UCs, to determine whether it can rescue the voiding abnormalities observed in UCav1.2-
/- mice or induces a phenotype resembling UCav1.2-/- in wild type mice. Aim 2. We will define urothelial
mechanosensory/voiding abnormality in UCav1.2-/- mice. We will test whether mechanosensation is altered in
UCav1.2-/- mice by abnormal urothelial ATP signaling. We will further test whether elevated urothelial ATP
signaling by ablation of ATP hydrolase Entpd3 in urothelium leads to voiding frequency as proposed in
UCav1.2-/- mice. In brief, our data indicate a crucial role of Cav1.2 in regulating bladder storage and voiding
function, supporting a novel mechanism on urothelial Cav1.2-mediated exocytosis and ATP signaling. A
complete understanding of this mechanism should answer the longstanding question of why Cav1.2
antagonists are of no benefit for LUTS patients, and potentially leads to novel therapeutics for LUTS treatment.

Public health relevance
Narrative: This project seeks to understand the details of how Cav1.2 calcium channel in urothelium modulates bladder storage and voiding functions. This study is important for the understanding of bladder pathologies, and will potentially lead to novel therapeutics to treat patients with bladder dysfunctions.